Experimental Pathology Laboratory (EPL)

Long-term research efforts in the EPL, in support of translational pathology include: developments of new hardware for the construction of tissue microarrays, the development of a tissue microarray instrument for frozen tissue, refinement of technologies for tissue micro-dissection. Additional efforts in the EPL focus on tissue preservation and storage, with efforts in the development of non-formaldehyde containing tissue fixatives, refinement to tissue impregnation systems to prevent tissue degradation and development of methods for freezing and storing tissue that prevent degradation. We filed invention reports in this fiscal year, both of which will be filed as preliminary patent applications. The research we support involves numerous types of cancers and other diseases, including COVID-19.